Characterizing Individuals' Cognitive Maps of their Village Social Networks

The pattern of social connections within a population (whether a school, firm, village, or online group) is
mentally perceived by those embedded within it. Such “cognitive social networks” (the mental maps people
make of the social world around them) are relevant to people’s social, mental, and physical well-being. More
formally, a sociocentric social network defines a set of dyadic relationships between individuals in a defined
population and can be represented by a 𝑁 × 𝑁 matrix A where each element Aij represents a tie between
individuals i and j, e.g., reported by individual i. But individuals not only form mental representations of their
own relationships, they also cognize relationships between others. For instance, an individual k may have a
perception of the relationship between i and j, say, that i is a friend of j. This yields a three-dimensional network
structure with entries 𝑖, 𝑗, 𝑘 ∈ 𝑁 × 𝑁 × 𝑁, where i is the “sender,” j the “receiver,” and k the “perceiver” of the
relationship. Humans are innately interested in tracking relationships, despite the cognitive burden. Such
knoweldge is often the basis for introductions, strategic information disclosure, and accessing social support. In
an ongoing longitudinal cohort involving 24,862 people aged 12-93 in 176 villages in rural Honduras, we have
mapped real, face-to-face network ties. Pertinently, we have 4,589 participants older than 50 at baseline (in
2016). Here, in new work involving an ongoing subset of 136 villages, we will assess how people form such
cognitive social maps, how these maps vary, and how these perceptions might matter. We have four specific
aims. In Aim 1, we ascertain the actual and perceived ties among individuals in the networks of 136 villages.
We will ask each resident, in every village, about their perceptions of the connections that might exist among
40 randomly chosen other pairs of people in their village. In Aim 2, we compare the actual ties seen in village-
level social networks to the ties perceived by members of the village. Our primary hypotheses are that ties
geodesically further away from individuals will be assessed less accurately; that more socially connected
individuals will be more accurate; and that older, male, or cognitively impaired individuals will be less accurate.
In Aim 3, we assess how the accuracy of perception depends on the characteristics of the perceived tie. Our
primary hypotheses are that ties between older individuals or ties involving fewer public displays of connection
will be less well perceived by others. In Aim 4, taking advantage of a randomized experiment, we evaluate if
being better able to accurately perceive social connections in one’s village is associated with one’s ability to
spread novel information, including health information. Our primary hypothesis is that more socially perceptive
individuals will have a greater ability to spread exogenously introduced information. Our results have
fundamental implications not only for the social neuroscience of aging, but for a practical understanding of
social isolation and whether and how social cognition can affect the spread of information and behaviors.

Public health relevance
PROJECT NARRATIVE People not only form social relationships themselves, but they also form an understanding of the relationships among other people. A lack of such understanding, or inaccuracies in perception, can contribute to social isolation in the elderly or reduce a person’s ability to influence the social world around them. Understanding all this gives us new insights not only into how the human mind works, not only into certain kinds of social isolation, but also into why some people are better able to foster the diffusion of innovative public health ideas and behaviors among their social connections.